Redox-based Fas Signaling in Allergic Airway Disease

PROJECT SUMMARY Excessive epithelial apoptosis and lack of proper epithelial restitution are believed to be critical to fibrogenesis. The death receptor Fas plays a cardinal role in epithelial apoptosis, and the subsequent development of pulmonary fibrosis. Similarly, changes in the oxidative environment, as well as endoplasmic reticulum (ER) stress are believed to be important in the pathogenesis of idiopathic pulmonary fibrosis (IPF), suggesting a causal link between redox and ER perturbations, Fas, epithelial apoptosis, and fibrogenesis. During the current funding cycle of this grant we discovered that the potency of Fas as a death receptor is enhanced following its S-glutathionylation, a form of protein oxidation. S-glutathionylation represents the conjugation of the antioxidant molecule glutathione to reactive protein cysteines (PSSG). We recently unraveled that in lung epithelial cells not all Fas is expressed on the surface but that a latent pool of Fas which is not fully processed into the ligand binding form, is localized in the ER. In response to stimulation of surface Fas with FasL, the protein disulfide isomerase, ERp57, induces rapid oxidative processing of Fas within the ER. We speculate that hydrogen peroxide (H2O2) produced during this process is responsible for S-glutathionylation, in a reaction that is catalyzed by glutathione S-transferase P (GSTP). These discoveries illuminate a new dimension of Fas- induced apoptosis ligand-triggered oxidative processing of latent Fas in the ER as a regulatory mechanism to regulate the strength of cell death. The exact oxidative events triggered within the ER remain unknown, and the functional role of H2O2 generated within the ER for epithelial apoptosis, and subsequent pathogenesis of fibrosis are unclear. The central hypothesis to be addressed herein is that ERp57-catalyzed processing of Fas leads to increases of H2O2 content in the ER. Increases in H2O2 are in turn required to permit GSTP-catalyzed S-glutathionylation of Fas, augmenting epithelial apoptosis, thereby leading to pulmonary fibrosis. In Specific Aim #1 we will determine the functional requirement of ERp57 in oxidative processing, and subsequent S- glutathionylation of Fas in lung epithelium, and the resultant development of pulmonary fibrosis. Specific Aim #2 seeks to explore the functional requirement of GSTP in S-glutathionylation of Fas, and the subsequent development of pulmonary fibrosis. In Specific Aim #3 we will assess the functional importance of H2O2 generated in the ER in Fas-dependent epithelial apoptosis and subsequent fibrogenesis. We will use complementary cell culture and mouse transgenic approaches, coupled to detailed analysis of these processes in lung tissues from patients with IPF as well as NSIP, using innovative and clinically relevant strategies. Completion of proposed experiments is likely to exert a substantial impact given that Fas, ER stress, and glutathione redox perturbations have been independently linked to the pathogenesis of fibrosis, and methodologies aimed at assessing or targeting S-glutathionylation may prove to be clinically relevant as diagnostic tools and potential therapeutics.

Public health relevance
PROJECT NARRATIVE This project seeks to identify the mechanisms whereby lung epithelial cells die, and the relevance this plays for the development of a scar in the lung. Specifically we will examine the importance of oxidants generated in a specific organelle, known as the endoplasmic reticulum (ER) in activating the cell death receptor, Fas in lung epithelial cells. The importance of the oxidant, hydrogen peroxide in this process will be determined by removing the enzyme that leads to its formation within the ER of epithelial cells. We also will use approaches to quench hydrogen peroxide from the ER and determine the impact for development of a scar. We will also determine whether these approaches stop the further progression of existing scars. We also will take advantage of a drug (TLK199) which is already in clinical trials to see if this drug can be used in setting of lung scarring, and will evaluate lung tissues for patients with idiopathic pulmonary fibrosis and non-specific interstitial pneumonia. This project is important in that it may demonstrate that therapeutics to prevent scars should be directed to normalizing oxidative processes in epithelial cells, and may therefore provide new opportunities to stop the process of scarring in the future. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Excessive epithelial apoptosis and lack of proper epithelial restitution are believed to be critical to fibrogenesis. The death receptor, Fas, plays a cardinal role in epithelial apoptosis and the subsequent development of pulmonary fibrosis. Similarly, changes in the oxidative environment, as well as endoplasmic reticulum (ER) stress, are believed to be important in the pathogenesis of idiopathic pulmonary fibrosis (IPF). All together, these observations suggest a causal link between redox and ER perturbations, Fas, epithelial apoptosis, and fibrogenesis. During the current funding cycle of this grant we discovered that the potency of Fas as a death receptor is enhanced following its S-glutathionylation, a form of protein oxidation. S-glutathionylation represents the conjugation of the antioxidant molecule glutathione to reactive protein cysteines (PSSG). We recently unraveled that in lung epithelial cells, not all Fas is expressed on the surface, but that a latent pool of Fas which is not fully processed into the ligand binding form is localized in the ER. In response to stimulation of surface Fas with FasL, the protein disulfide isomerase, ERp57, induces rapid oxidative processing of Fas within the ER7. We speculate that hydrogen peroxide (H2O2) produced during this process ultimately leads to S-glutathionylation, in a reaction that is catalyzed by glutathione S-transferase π (GSTP) (see model). These discoveries illuminate a new dimension of Fas-induced apoptosis; "ligand-triggered oxidative processing of latent Fas in the ER" as a regulatory mechanism to regulate the strength of cell death. The exact oxidative events triggered within the ER remain unknown, and the functional role of H2O2 generated within the ER for epithelial apoptosis, and subsequent pathogenesis of fibrosis are unclear. The central hypothesis to be addressed herein is that ERp57- catalyzed processing of Fas leads to increases in H2O2 content within the ER. Increases in H2O2 are in turn required to permit GSTP-catalyzed S-glutathionylation of Fas, augmenting epithelial apoptosis, thereby leading to pulmonary fibrosis. Proposed model: Following ligation of mature Fas on the surface, a Ca2+- dependent signal induces ERp57-mediated oxidative processing of latent Fas (Fas- SH to Fas-S-S) in the endoplasmic reticulum (ER). Increases in hydrogen peroxide (H2O2) following regeneration of ERp57 lead to a sulfenic acid intermediate of Cys 294 (Fas-SOH). GSTP subsequently catalyzes S-glutathionylation (Fas-SSG) which increases apoptosis. ER-localized peroxiredoxin-4 (Prx4) is postulated to quench H2O2.This proposal will experimentally focus on epithelial cells, not myofibroblasts, as failure to restore intact lung epithelia is an important signal in fibrogenesis. We do however acknowledge the importance of the interface between epithelial cells and fibroblasts in fibrogenesis, and will monitor proposed pathways in fibroblasts as well. Specific Aim #1: To determine the functional requirement of ERp57 in oxidative processing, and subsequent S-glutathionylation of Fas in lung epithelium, and the resultant development of pulmonary fibrosis. We will first determine expression patterns and oxidation state of Fas and ERp57 during the pathogenesis of bleomycin- or adenovirus expressing active transforming growth factor β1 (AdTGFβ1)-induced fibrosis, as well as in lungs of patients with IPF. We will conditionally ablate ERp57 from lung epithelial cells and determine the consequences for oxidation of Fas, and the progression of established fibrosis using both models. The causal role of Fas-SSG in fibrogenesis will be assessed using a Fas mutant that cannot be S-glutathionylated. Specific Aim #2: To determine the functional requirement of GSTP in S-glutathionylation of Fas, and the subsequent development of pulmonary fibrosis. We will determine expression of GSTP in mouse models of fibrosis and patients with IPF. We will ablate GSTP1 at different times with siRNA to determine the impact on Fas-SSG on the progression of progression of established disease. We will also synthesize a pharmacological inhibitor of GSTP, TLK199, a drug already in clinical development, and determine its impact on Fas-SSG, and established fibrosis using both models. Specific Aim #3: To determine the functional importance of H2O2 generated in the ER in Fas-dependent epithelial apoptosis and subsequent fibrogenesis. Redox changes in the ER will be assessed using ER redox sensors, or overoxidation of ER-localized peroxiredoxin 4 (Prx4) in epithelial cells stimulated with FasL. The extent of overoxidation of Prx4, as a marker of ER oxidative stress will be assessed during the pathogenesis or fibrosis in both mouse models or in IPF patients. We will create transgenic mice that conditionally overexpress Prx4 within the lung epithelium, and determine whether enhanced expression of Prx4 at a time when collagen deposition is increased, protects against the progression of bleomycin- or adTGFβ1-induced fibrosis. Completion of proposed experiments is likely to exert a substantial impact given that Fas, ER stress, and glutathione redox perturbations have been independently linked to the pathogenesis of fibrosis, and methodologies aimed at assessing or targeting S-glutathionylation may prove to be clinically relevant as diagnostic tools and potential therapeutics.